Pilot Project Program

PROJECT SUMMARY
The Pilot Project Program (PPP) has played a key role in pursuing the mission of the University of Cincinnati's
Center for Environmental Genetics (CEG) with a thematic focus on gene-environment interaction (GxE)
research. The overall objective of the PPP is to provide seed support for new research initiatives in
environmental health sciences (EHS) that will shed new light on the GxE research focus of the CEG. The goal
is to allow investigators, either established or new to the field, to obtain significant preliminary data that can
become the basis of new NIH/NIEHS grant proposal(s) and associated publications. To accomplish this, the
following six different award mechanisms will be used: New (early stage) Investigator Award, Innovator Award,
New-to-EHS Investigator Award, Affinity Group Award, Translation and Community Engagement Award, and
Time-Sensitive Response Award. The CEG-PPP relies on both internal and external reviews of its pilot
applications and has developed an Inter-Center Reviewer Consortium involving four NIEHS-funded P30 EHS
Centers. The review process is aligned closely with the format followed at the NIH. Review criteria and the
score scale (1-9) similar to NIH review process allow us to provide a meaningful feedback to the applicants as
well as help the Center train its junior faculty in the NIH-type review process. The PPP has a built-in
mechanism to track the progress and outcome of the pilot awards through a regular progress reporting
(including professional presentations, publications, extramural grants) and an annual Pilot Project Symposium
directed at a broader audience across the CEG membership and the university campus. Overall, the PPP
program is an important vehicle in multiple ways such as helping junior investigators in their career pursuits,
recruiting new investigators into the field of EHS research, stimulating novel research ideas and filling the gaps
in CEG research agenda, promoting facility cores usage, building trans-disciplinary research teams and
facilitating translation and community engagement activities. In essence, the PPP serves to integrate all other
components of the Center through its award mechanisms, and helps the individual CEG cores realize their
goals. The performance of the CEG-PPP will continue to be reviewed by the Center's Internal Advisory Board
and External Advisory Board and judged by two key criteria: Return on Investment in terms of subsequent
extramural funding and Publications emanating from the funded pilot projects. The CEP-PPP strives to
maintain its excellence in channelizing the pilot funds to the most promising projects in EHS and supporting
new investigators (both Early Stage and New-to-EHS) to facilitate obtaining extramural funding on new and
innovative directions in GxE research.